MRI Bone Texture: A Novel Biomarker for Assessment of Bone Quality and Prediction of Complications in Patients Having Spine Fusion Surgery

Project Summary
Spine fusion surgery is one of the most common, and complex, orthopedic procedures. Complications occur in
over 30% of cases, highlighting the need to identify modifiable factors associated with these negative sequelae.
Bone quality is a critical determinant of post-operative outcomes, as stability of hardware in bone and de novo
bone formation are required for successful fusion. Despite the importance of bone quality to post-operative
outcomes, there are limited tools for pre-operative detection of abnormal bone in candidates for fusion. The most
common clinical tool for skeletal assessment, dual energy x-ray absorptiometry (DXA), is subject to artifact from
spinal abnormalities and infrequently performed for pre-operative evaluation. High resolution peripheral QCT
(HRpQCT) can detect pre-operative skeletal abnormalities and predict complications after fusion but is a
research tool not available in clinical practice. In contrast, MRI is routinely performed prior to fusion, for diagnosis
of spinal disease and surgical planning, making an MRI-based technique ideal to screen for pre-operative
skeletal deficits. Our group has recently developed a novel method to evaluate bone quality using standard,
clinically acquired MRIs which analyzes the irregularity, or heterogeneity, of trabecular bone texture. In prior
work, we found that postmenopausal women with fractures had greater heterogeneity of bone texture than age-
matched controls. The proposed study will assess MRI trabecular bone texture as a new technique to detect
poor bone quality, predict complications, and track post-operative skeletal changes in patients undergoing spinal
fusion. We hypothesize that pre-operative MRI bone texture will relate to volumetric BMD (vBMD) and
microarchitecture by HRpQCT and will predict skeletal complications after surgery. Post-operative changes in
MRI bone texture will relate to baseline patient characteristics and clinical post-operative treatment regimen,
including use of anabolic agents. We will prospectively enroll 100 patients having lumbar spine fusion and follow
them for one year. Baseline DXA, HRpQCT, and our MRI-based method will be performed. MRIs will be repeated
at 6 months post-operatively to determine whether early changes in MRI bone texture relate to patient
characteristics, medication use, and predict complications. CT scans will be performed at one year to assess
skeletal complications and completeness of fusion. This proposal aims to: 1) Investigate the relationship between
pre-operative MRI bone texture and HRpQCT measurements of vBMD and microarchitecture; 2) Investigate
whether MRI bone texture predicts skeletal complications after fusion; 3) Assess longitudinal changes in bone
texture and the clinical factors that influence these changes in patients after spine fusion. The long-term goals
of our research are to improve identification of patients at high risk for post-operative complications and provide
knowledge that will advance future interventional trials. In subsequent work, we plan to extend this technique to
other orthopedic populations. Ultimately, we hope to improve the outcomes of patients undergoing fusion and
other high-risk orthopedic surgeries by facilitating the creation of new peri-operative treatment paradigms.

Public health relevance
Project Narrative The lack of clinically available tools for identification of bone abnormalities in patients who undergo spine fusion surgery contributes to high rates of complications after surgery. This prospective study will investigate a new technique, based upon standard clinical MRI scans, to detect abnormal bone in patients before surgery, monitor changes in bone and predict complications that occur after surgery. The long-term goals of our research are to improve identification of patients at high risk for complications after surgery and provide knowledge that will help plan follow-up treatment studies.